Impact of sensorimotor pathway integrity on hand motor recovery in stroke survivors

PROJECT SUMMARY / ABSTRACT
The objective of the parent grant (R01 HD094731) is to determine if combining TheraBracelet with hand task
practice is superior to hand task practice alone for recovery of hand function post-stroke in an adequately
powered study. The parent grant focuses on determining the effect of TheraBracelet on hand functional recovery,
sensorimotor grip control, and neural communication. This diversity supplement will provide a new insight into
how sensorimotor pathway integrities explain individual patients’ hand functional recovery. Specifically, three
sensorimotor pathway integrities will be examined including the sensory pathway, sensorimotor integration, and
motor pathway, all measured as part of the assessment for neural communication. This supplement has two
aims. Aim 1: Determine the effects of the three sensorimotor pathway integrities on motor recovery. It is
hypothesized that the integrity of all three components of the sensorimotor pathways at baseline will
independently contribute to the extent of motor recovery with upper extremity rehabilitation intervention. Aim 2:
Determine neuroplasticity of the three sensorimotor pathways with motor recovery. It is hypothesized that the
integrity of the three components of the sensorimotor pathways will improve from pre to post upper extremity
rehabilitation intervention. Impact: This diversity supplement research will elucidate the importance of
considering the sensory pathway and sensorimotor integration in addition to the motor pathway integrity for post-
stroke motor recovery prognosis (Aim 1) and neuroplasticity (Aim 2). Consideration of all neural pathways
associated with sensorimotor control, rather than just the motor pathway, is expected to enhance prognosis of
motor recovery following stroke. In addition, the complete picture of the changes occurring in the sensorimotor
pathways is expected to elucidate the neural mechanisms of motor recovery. Most importantly, this award will
foster the candidate with a disadvantaged background (Ms. Jenna Blaschke) as an OTD/PhD researcher. The
training activities will focus on developing new research skills for Ms. Blaschke to perform the supplement
research and begin her research career. Specifically, Mr. Blaschke will (1) enhance the overall knowledge of the
neurorehabilitation research field, (2) develop proficiency in quantifying, analyzing, and interpreting EEG and
TMS for sensory, sensorimotor integration, and motor pathway integrities and their relations to motor recovery,
and (3) advance her professional development including dissemination, grantsmanship, development of a
successful application for a PhD program. The training from this supplement award will form the foundation for
her future career as a clinician researcher to improve post-stroke motor recovery and diversify biomedical
workforce.

Public health relevance
PROJECT NARRATIVE The proposed diversity supplement aims to reveal how individual stroke survivors recover hand function based on their residual neural functions. Thus, the supplement informs the new insights for post-stroke hand functional recovery prognosis and mechanisms, thereby ultimately contributing to improved rehabilitation care for stroke survivors. This supplement also will foster development of the candidate from a disadvantaged background towards a clinician-researcher career in rehabilitation research and to enhance diversity in the biomedical workforce.